Addressing Social Determinants of Health in Systemic Lupus Erythematosus

Lupus, a chronic autoimmune disease affecting multiple organ systems, encompasses a diverse range of
clinical manifestations. Systemic lupus erythematosus (SLE), the most prevalent form of lupus, presents with
considerable heterogeneity, posing substantial challenges in disease management for patients, providers, and
caregivers. Despite overall improvements in SLE outcomes, disparities persist across racial and ethnic
minorities and socially disadvantaged populations. For instance, Black and Hispanic individuals exhibit higher
SLE disease activity, poorer pregnancy and cardiovascular outcomes, reduced quality of life, and elevated
mortality rates. These disparities often stem from inadequate social determinants of health (SDoH), which also
contribute to SLE deterioration and suboptimal outcomes.
Recognizing the critical role of addressing these unmet social needs in SLE management, we integrate real-
world data (RWD), artificial intelligence (AI), and natural language processing (NLP) to tackle data and methods
challenges and propose to develop a social risk management tool that aims to transform SLE clinical care by
integrating social care, facilitating a much-needed paradigm shift in US health care delivery. This SBIR project
is an interdisciplinary collaboration among Polygon Health Analytics LLC and the University of Florida.
By leveraging RWD from the OneFlorida+ network and an exposome database capturing contextual SDoH,
we aim to (1) establish an individualized polysocial risk score (iPsRS), which assesses increased social risk
essential to SLE flares, and (2) employ causal AI models to estimate the causal effect of SDoH on SLE flares
to identify the effective targets for social interventions. (Aim 1) Moreover, collaborating with diverse
stakeholders, our team will prototype a digital health tool named iSMILE (Individualized Social Risk
Management In Systematic Lupus Erythematosus CarE) through a user-centered design (UCD) approach and
develop thoughtful qualitative studies to develop next-step implementation recommendations and
commercialization plans. (Aim 2)
This project is highly feasible and potentially transformative for creating novel social care for SLE patients. It
will deliver a prototype of a social risk management tool tailored for individual SLE patients with input from various
stakeholders along with a set of prioritized strategies for implementation. We will also refine a step-by-step
commercialization plan to identify a viable business model, targeting various stakeholders (e.g., patients, payers,
and pharma companies), in order to further develop the ISMILE into a real commercial tool with a bigger scope
through a SBIR Phase II project.

Public health relevance
Systemic lupus erythematosus (SLE) is a highly heterogeneous disease posing significant management challenges for patients and providers, with worse outcomes for Black and Hispanic women and those with inadequate social determinants of health (SDoH). Advancements in real-world data and artificial intelligence provide a unique opportunity to develop novel technological solutions, that integrates social care into traditional clinical care and facilitates a much-needed paradigm shift in the US health care delivery. This proposed SBIR Phase I project aims to develop an individualized social risk management algorithm and implement it in a software prototype to help SLE patients to manage their social needs and improve their SLE outcomes.